Incline Training to Personalize Motor Control Interventions after Stroke

The long term goal of this research is to advance personalization of walking rehabilitation for individuals post-
stroke by developing therapeutic strategies targeting an individual’s specific motor control deficit. Stroke is an
incredibly heterogeneous population, and while various therapeutic approaches have produced large effects in
some individuals, group effects are often minimized by those who fail to respond to the intervention, leading to
a paucity of efficacious randomized controlled trials. In addition, evidence supporting mechanisms by which
walking is improved is limited, and we currently lack models predicting which individuals are likely to respond to
an intervention and the mechanisms by which they improve. An urgent need exists to maximize treatment effect
by targeting specific motor control impairments and improve predictive capability by developing theory-based
clinical decision-making frameworks to translate interventions tailored to specific deficits for walking rehabilitation
after stroke. Our overall goal for this project is to test a motor control deficit-based treatment approach that we
developed, in order to provide information necessary for future translation of personalized interventions. We
previously published the existence of distinct post-stroke motor control deficits based on the percentage of
overall propulsive forces generated by the paretic leg termed paretic propulsion (Pp), a widely accepted
biomechanical outcome measure that we developed. 1) Low Pp is associated with large and early paretic flexor
EMG activity, lengthened paretic step length, and decreased paretic hip extension; and 2) High Pp pattern is
characterized by decreased knee flexion during paretic swing, shortened paretic step length, and prolonged
paretic hip extension. Our pilot data reveal that individuals with these walking patterns are most effectively
rehabilitated by unique treatment strategies: 1) Low Pp by walking on an inclined treadmill requiring increased
force production; and 2) High Pp by walking on a declined treadmill, promoting effective stance to swing
transitions through normalization of joint kinetics and kinematics. The hypothesized ideal training strategy
(INCLINE for low Pp and DECLINE for high Pp) is the personalized strategy and will be compared to non-
personalized strategies (DECLINE for low Pp and INCLINE for high Pp). Both personalized strategies will be
compared to a CONTROL group training on a flat treadmill at equivalent amounts of walking activity. Pilot training
data demonstrate that personalized strategies demonstrate a larger effect on self-selected walking speed
(SSWS) and symmetry of Pp. Thus, the purposes of this proposal are to compare clinical and biomechanical
outcomes from personalized strategies to both non-personalized strategies and control interventions and to
identify the variables that predict meaningful changes in SSWS. To accomplish these purposes, we will equally
randomize 60 individuals (30 with high Pp and 30 with low Pp) between the ages of 25 and 75 with chronic stroke
to one of three interventions (INCLINE, DECLINE, or CONTROL). Training will occur 3x/week for 4 weeks and
will be evaluated pre- and post-training and at a one-month follow-up. Aims will evaluate the improvement in
functional and biomechanical outcomes in both the INCLINE and DECLINE groups compared to a CONROL
group. A third aim will determine the factors that contribute to response to INCLINE and DECLINE training
defined as an improvement of 0.16 m/s in SSWS based on responder outcomes in previous locomotor
rehabilitation trials. Selecting the correct intervention for a given motor control deficit, as opposed to applying a
one-size-fits-all strategy, is likely to aid in maximizing clinical effects of locomotor rehabilitation interventions after
stroke. This approach is based on building capacity to improve motor control deficits as opposed to training
specifically to the targeted functional outcome. Determining the efficacy of personalized interventions on clinical
and biomechanical outcomes and determining the factors that predict response has high likelihood of improving
locomotor rehabilitation for Veterans who have experienced a stroke.

Public health relevance
Stroke is the leading cause of disability, as many of those affected demonstrate difficulty with movement and walking. Rehabilitation post-stroke can be challenging and often ineffective because no two stroke survivors present with the same mobility impairments, yet the same physical therapy interventions are utilized. Thus, a need exists to personalize rehabilitation techniques to improve function and mobility post-stroke. The proposed innovative research will test a framework created to identify the most effective intervention based on a participant’s specific motor control problems. We plan to study how self-selected walking speed is impacted by a four-week walking program that incorporates either walking on an inclined or declined treadmill compared to walking on a flat treadmill. We will determine the best intervention for each problem and identify predictors of response. Selecting the correct intervention for personalized motor control problems, as opposed to applying a one-size-fits-all strategy for rehabilitation, is likely to improve walking function in Veterans after stroke.